Biomarkers of Kidney Secretory Function for Discriminating Risk of Hyperkalemia

PROJECT SUMMARY
Hyperkalemia is a common and potentially life-threatening electrolyte disturbance. The risk of hyperkalemia is
higher in individuals with heart failure (HF) and chronic kidney disease and with the use of certain medications,
such as spironolactone. Current methods to identify individuals at increased risk of hyperkalemia are
rudimentary. Potassium is primarily eliminated by the kidneys through glomerular filtration and tubular
secretion, but currently only glomerular filtration is considered when evaluating risk for hyperkalemia. Novel
biomarkers of kidney tubular secretion have been strongly linked with tubule fibrosis and we have recently
demonstrated that a lower secretion score, a composite score from secretion biomarkers, is associated with a
higher risk of incident hyperkalemia. Many medications, such as spironolactone, are eliminated through
secretion. Kidney tubule secretion biomarkers have been associated with the clearance of medications
dependent on kidney secretion for elimination. The Spironolactone for Heart Failure with Preserved Ejection
Fraction (TOPCAT) trial is a multicenter international clinical trial that enrolled 3445 patients with HFpEF and
randomized participants to spironolactone versus placebo. In TOPCAT, rates of hyperkalemia were 18.7% in
spironolactone arm and 9.1% in the placebo arm. In this TOPCAT ancillary study, we will measure kidney
tubule secretion biomarkers with the specific aims to: 1) determine if a novel panel of tubular secretion
biomarkers identifies HF patients at higher risk for hyperkalemia in TOPCAT, and 2) determine if tubule
secretion biomarkers are associated with improvements in heart failure symptoms and natriuretic peptide
levels from spironolactone therapy among HF patients in TOPCAT. The results of this study will provide
evidence for an innovative method to risk stratify individuals for risk of hyperkalemia prior to starting
hyperkalemia provoking medications, and lead to a new line of investigation wherein we move secretion
biomarkers from research towards clinical practice with the ultimate goal of maximizing benefits while
minimizing risks of drug dosing and drug-drug interactions for secreted drugs.

Public health relevance
Project Narrative Hyperkalemia (a high potassium level in the blood) is a frequent electrolyte abnormality and is associated with an increased risk of death. The kidney is the primary organ for excretion of potassium from the body, but currently only the kidney's ability to filter potassium from the blood is measured; however, the secretion of potassium, which is an important mechanism for potassium elimination, is not measured. This proposal will measure novel biomarkers that reflect kidney tubule secretion and determine their association with the risk of developing hyperkalemia in a cohort of heart failure patients from the NHLBI sponsored TOPCAT study.